Unraveling the Role of Clonal Hematopoiesis in Neurodegenerative Diseases

ABSTRACT
Clonal hematopoiesis (CH) has been linked to an increased risk of cancer and cardiovascular diseases. However,
its potential implications in various age-related conditions, particularly neurodegenerative diseases, remain
insufficiently explored. Recent research has highlighted the protective effect of clonal hematopoiesis of
indeterminate potential (CHIP) against Alzheimer's disease (AD), emphasizing the need for further investigation
into CH's role across a spectrum of neurodegenerative diseases. Yet, the involvement of CH in other
neurodegenerative diseases, such as Parkinson's disease (PD), dementia with Lewy bodies (DLB), and
amyotrophic lateral sclerosis/frontotemporal lobar degeneration (ALS/FTD), has not been comprehensively
investigated. Additionally, the distinct implications of other types of CH, including autosomal mosaic
chromosomal alteration (mCA) and loss of the Y chromosome (LOY), on these diseases have yet to be
thoroughly examined. To fill this knowledge gap, this project will unravel the disentanglement of commonalities
and disparities in associations between different CH types and neurodegenerative diseases by leverage a large
amount of high-throughput sequencing data of AD, PD, DLB, and ALT/FTD. Moreover, this project will gain
insight into the underlying mechanisms of its potential varying effects of CH across the diseases by utilizing
extensive functional genomics data. To this end, this project has three specific aims. In aim 1, we will uncover
the associations of different CH types with neurodegenerative diseases by leveraging whole-genome sequencing
data from multiple cohorts. We will also perform Mendelian randomization to support causal associations
between CH and neurodegenerative diseases. In aim 2, we will characterize inter-individual transcriptomic
variability in individuals with and without CH across central nervous system tissues and myeloid cells by
leveraging previously published data, including bulk, sorted, and single-nuclei RNA-seq (snRNA-seq), as well as
assay for transposase-accessible chromatin using sequencing (ATAC-seq), from disease cohorts. We will also
perform cell type-specific transcriptome and chromatin accessibility characterization by detecting cells with
autosomal mCA and LOY from snRNA-seq/ ATAC-seq. In aim 3, we will employ two innovative experimental
approaches: (1) snRNA-seq paired with genotyping of transcriptome (GoT) and (2) iPSC-derived human
microglia-like cells (iMGL) to delve into the cell type-specific functional impacts of CHIP. Aim 3 will significantly
complement Aim2 since cell type-specific characterization of CHIP is challenging unlike autosomal mCA and
LOY. Our preliminary results suggest varying effects of CHIP and LOY on the risk of different neurodegenerative
diseases and functional impact of LOY, especially highlighted in microglia. These findings validate and motivate
our work plan, driving us to pursue further studies in this project. The comprehensive understanding of CH's role
in neurodegenerative diseases achieved through this project will make significant contributions to the discovery
of novel treatment options and the discovery of biomarkers for predicting the risk or progression of these diseases.

Public health relevance
NARRATIVE We aim to investigate the role of clonal hematopoiesis (CH) in neurodegenerative diseases. Recent research highlights CH protective effect against Alzheimer's, underscoring the need for a comprehensive exploration across various neurodegenerative diseases. Using innovative methods and abundant sequencing datasets, we aim to uncover CH's complex implications, potentially informing tailored therapies and predictive biomarkers.